Fibroadipogenic progenitor cells as drivers of angiogenesis during muscle regeneration

ABSTRACT
Skeletal muscle comprises nearly half of body mass and is subject to traumatic injuries, particularly of the
extremities. Damaged muscle mass and function must be restored promptly to minimize physical distortion and
prevent long-term disabilities. Furthermore, poor outcomes impose significant emotional and financial burdens
on affected individuals and their families. An aspirational goal of the NICHD is to advance the ability to regenerate
human limbs by using emerging technologies to activate the body’s own growth pathways and processes. Under
most circumstances damaged muscle is efficiently regenerated through a coordinated multicellular response
involving muscle stem cells (satellite cells, SCs), endothelial cells (ECs), and fibroblasts or fibroadipogenic
precursor cells (FAPs) as well as other resident and infiltrating cell types. However, after the loss of tissue over
a critical threshold (volumetric muscle loss, VML), tissue regeneration does not occur and neither mass nor
function are regained. The molecular and cellular mechanisms underlying the distinction between subthreshold,
regenerating wounds vs. nonregenerating VML are not yet sufficiently understood, posing a critical roadblock to
development of translational interventions. A novel punch biopsy model of injury and regeneration developed in
the PI’s laboratory using the mouse gluteus maximus muscle highlights the sequential activity of FAPs, ECs, and
SCs in successful muscle regeneration. A key observation is that if local FAPs are removed, both angiogenesis
and myogenesis fail to occur, making the subthreshold injury instead resemble VML. Whether FAPs effect this
relationship by direct actions on ECs, myogenic cells, or both is unknown. Therefore, this research project
proposes to: 1) confirm the requirement for FAPs in permitting healing of a subcritical VML injury; 2) test the
ability of a candidate molecule, periostin, to rescue microvascular and myofiber regeneration in wounds lacking
FAPs; 3) determine whether periostin signals directly to ECs, myogenic cells, or both; and 4) perform an unbiased
proteomic screen for additional signaling molecules either secreted directly by FAPs or induced in ECs or
myogenic cells by FAPs that may promote the regeneration of intact muscle. These experiments will leverage
the team's collective expertise in microvascular imaging, muscle regeneration, FAPs biology, and biomaterials
to identify, characterize, and functionally test key cellular and molecular factors differentiating between muscle
injuries which heal successfully and those which cannot. If successful, this research project will identify
molecules and methods which have the potential to be translated into therapies designed to improve clinical
outcomes for disabled individuals, thereby addressing a key unmet need in both basic and applied muscle
biology.

Public health relevance
PROJECT NARRATIVE Skeletal muscle comprises nearly half of body mass and is subject to traumatic injuries, particularly in the extremities. Damaged muscle must be restored promptly to minimize long-term disabilities. This research project focuses defining the role of fibroadipogenic precursor cells (FAPs) in driving angiogenesis to promote skeletal muscle regeneration and elucidating the role of periostin as a key molecular signal in the recovery process.